Metabolomics of ICH recovery (METABOL-ICH)

Project Summary:
Stroke is the third leading cause of death and the leading cause of disability in the United States.
Intracerebral hemorrhage (ICH) is the subtype of stroke with the highest morbidity and mortality
and demonstrates marked race/ethnic differences. Specifically, Black Americans and Hispanic
Americans demonstrate approximately double the incidence rate of ICH compared to people of
European descent and have their hemorrhage an average 10 years earlier in life. ICH activates
several metabolic pathways involving glycogen, sphingolipids, tryptophan/kynurenine, and
others. Identifying the specific metabolites that are associated with poor outcomes would provide
specific targets for novel therapeutic interventions.
In the current proposal, we leverage existing samples from two large genetic epidemiology studies
of ICH with over-representation of disproportionately affected Black and Hispanic populations: the
Ethnic/Racial Variations of Intracerebral Hemorrhage (ERICH-U01NS069763) and the Recovery
and Outcomes after Stroke (ROSE-U01NS100417) studies. We will leverage 1273 non-Hispanic
Black, non-Hispanic White and Hispanic ICH participants with 90-day outcomes, and
demographically and geographically matched controls with plasma samples from 41 sites across
the United States. Participants were prospectively recruited, underwent detailed interview, chart
abstraction and neuroimaging review. We propose to utilize a comprehensive and validated
metabolomic approach to assess 5400 metabolites. To these findings, we are able to bring a
wealth of already phenotyped covariates including neuroimaging variables such as white matter
hyperintensity and atrophy, treatments including reversal of anticoagulants and blood pressure
treatment as well as subsequent events such as re-hemorrhage, infections, and cardiac events.
The proposal represents the largest comprehensive assessment of metabolomics after ICH to
date. A key component of our research is that features such as race, sex and volume of ICH are
unalterable traits, but may have markedly different metabolomic responses which can be
addressed. Understanding these differences is thus key to prioritizing targets with greatest
potential impact as treatments.
Finally, we will seek to identify the independent, treatable targets for future interventions by
exploring the relative contributions of clinical, demographic, neuroimaging, genetic and
metabolomic risk factors for outcomes to generate and test machine learning predictive models
for 3-month outcomes after ICH.

Public health relevance
Title: Metabolomics of Intracerebral Hemorrhage Outcomes (METABOL-ICHs) Project Narrative: Black American and Hispanic populations have roughly double the risk of brain hemorrhage, and at a younger age, compared to populations of European descent. Brain hemorrhage is a toxic, often deadly or highly disabling event, that leads to a wide variety of metabolic reactions and yet to date, a comprehensive evaluation of these reactions has not been performed. We propose to perform a comprehensive evaluation of the metabolic response from brain hemorrhage as well as to identify those metabolic responses that associate with outcomes.